Genetic mapping of the inflammatory adaption circuit in epithelial stem cells

PROJECT SUMMARY
Epithelial stem cells reside in the major barrier tissues, governing homeostatic regeneration and injury repair. As
long-lived and indispensable cells, epithelial stem cells must endure bouts of inflammation. This ability is
especially critical during wound healing when many immune cells infiltrate the tissue. These immune cells play
important roles in controlling infections and clearing dead cells, but they also release toxic substances and create
a very harsh inflammatory environment for stem cells. It has long been assumed that stem cells are vulnerable
and must be protected within an ‘immune privileged’ niche. However, our recent study challenged this idea. We
have found that, upon wounding, the epithelial stem cells must be mobilized to exit their natural niche and migrate
into a highly inflammatory wounding environment for regenerating the damaged tissue. If stem cells failed to
adapt to inflammation, it could cause nonhealing wounds, which still affect millions of people worldwide, causing
significant economic and public health burdens. It is unclear how epithelial stem cells achieve self-renewal and
differentiation within an inflammatory environment while preventing collateral damage. Addressing this question
will transform our understanding of the fundamental biology underlying cellular fitness, stress tolerance, tissue
homeostasis, barrier integrity, and wound repair. Driven by its importance, the central question of this proposal
is to understand how epithelial stem cells adapt to the inflammatory environment and how this adaptive function
promotes wound repair. A significant gap in technology preventing a thorough understanding of wound healing
and stem cell adaptive functions is the lack of effective tools for rapid gene discovery and mechanistic studies in
mouse models. To overcome this hurdle, in this project, we will adopt an ultrasound-guided in utero microinjection
technique to establish a new experimental framework for rapid, functional, and mechanistic investigation of
genes involved in stem cell adaptation and wound healing directly in live mice. We will leverage this experimental
framework to deploy a full-fledged platform that will place us in a unique position to: first, design in vivo CRISPR
screening platforms and stem cell interactome sensors to dissect how epithelial stem cells can remodel the fate
and activities of surrounding immune cells to build a temporary protective niche, shielding stem cells from
inflammatory damage. Second, we will focus on devising an in vivo Perturb-seq-based framework and
cell/organelle tagging system to identify how epithelial stem cells reprogram their metabolism to tolerate
inflammation. In sum, this proposal has the potential to reveal critical information and build a solid foundation for
future efforts in developing strategies to manage non-healing wounds.

Public health relevance
PROJECT NARRATIVE A remarkable feature of epithelial stem cells is their ability to rapidly detect, respond, and endure environmental perturbations. This project aims to develop an integrative genetic platform to investigate how epithelial stem cells sense and adapt to inflammation by modulating immune cells to rebuild a new niche and by reprograming their metabolism to reduce inflammatory damage. The goal of this project is to understand how these adaptive functions of epithelial stem cells promote successful wound repair.